P30 Core Grant for Vision Research

Project summary- Biobank Core
The overall goal of the BioBank core is to help investigators collect and store biological samples from
patients with ocular disorders, and to link those samples with molecular and clinical data. The
collection of biological samples from patients with ocular disorders is an integral part of many
research programs at Massachusetts Eye and Ear (MEE). By providing a central facility for sample
collection and processing, the BioBank resources reduce duplicated efforts among investigators.
Centralized storage and tracking using state-of-the-art programs ensures sample maintenance and
protection and minimizes sample loss and mix-up. Linking individual samples to clinical data using the
electronic medical record system (RPDR) as well as databases with molecular data enables
sophisticated study of large datasets that enhances the overall quality of MEE investigations.
Additionally, providing assistance with sample collection helps young investigators and clinical
scientists who may not have funding to collect useful samples from patients with interesting clinical
disease that would benefit from further study. The availability of patient sample resources also
supports new investigations and collaborations, especially between basic and clinical scientists
forming another bridge between basic and clinical research at MEE.